Central Nervous System Drug Delivery Techniques

Preclinical Studies

Real-time imaging of convection-enhanced delivery (CED)

Monitoring CED delivery in real-time is essential because the treatment site and pathologic condition affect an infusates volumetric and anatomic distribution. We developed small and large molecular weight computed tomographic (CT)- and magnetic resonance (MR)-imaging tracers for real-time CED imaging. These tracers can be co-infused with therapeutic agents. We showed that co-infusing therapeutic molecules and surrogate imaging tracers allowed real-time serial CT- or MR-imaging to monitor the CED of putative therapeutic agents. Non-invasive monitoring of infusate delivery in real-time permitted exploration of many parameters (i.e., rate, flow characteristics, anatomic boundaries) associated with CED, revealed areas for improvement in CED technology (i.e., catheter design, pump design), improved infusion accuracy, assessed adequacy of target coverage by infusate, and predicted the infusions effectiveness to treat targeted disease tissue.

Neurodegenerative disorders

The properties of CED allow it to selectively manipulate distinct subsets of neurons (and other cell types) for therapy. In laboratory animals, we studied convection-enhanced delivery of muscimol, a GABA-A agonist. A solution of muscimol and gadolinium-DTPA was infused bilaterally into the subthalamic nuclei. The distribution of muscimol was seen in real-time by MRI because of the presence of gadolinium-DTPA in the infusion solution. We also noted behavioral changes and safety. We published our report on muscimol distribution and behavioral effects in research animals in 2019. This work was performed to support a clinical trial of muscimol infusion into the subthalamic nucleus during deep brain stimulation (DBS) surgery, exploring the potential mechanism of neural inhibition from high-frequency electrical stimulation of the subthalamic nucleus in Parkinsons disease. Convection-enhanced delivery of agents acting on specific neurotransmitters and brain structures is a chemical neurosurgery technique that potentially could treat patients with degenerative disorders.

Epilepsy

Surgically remediable drug-resistant epilepsy (DRE) usually originates from a hippocampal seizure focus. DRE could be relieved without surgically removing the hippocampus by selectively suppressing the epileptic focus. Our laboratory showed that convectively perfusing the epileptic focus could reduce rodent seizures. In 2019, we published a manuscript describing botulinum toxin, an agent inactivating synaptic activity, infused by CED into the non-human primate hippocampus. We also studied the toxicity and distribution of chronically infused muscimol into the hippocampus of 10 non-human primates. Depth electrode studies showed that muscimol suppressed electrical activity in the hippocampus. Autoradiography of infused muscimol showed muscimol delivery throughout the hippocampus. Muscimol CED was tolerated without a brain injury or permanent adverse effects. We published this study in 2020.

Clinical Trials

Neuro-Oncology

Diffuse midline glioma of the pons, previously known as Diffuse Intrinsic Pontine Glioma (DIPG), is an unresectable, uniformly fatal pediatric brain tumor. Radiotherapy is palliative. Putative therapeutic compounds developed and available to treat diffuse brainstem gliomas are ineffective and cannot cross the blood-brain barrier. To overcome this limitation, we investigated the CED of a targeted anti-glioma agent (interleukin-13 bound to Pseudomonas toxin, IL13-PE) in the brainstem. We co-infused a surrogate MR-imaging tracer (gadolinium-DTPA) to monitor drug distribution. Based on this delivery models safe and successful use in rodents and primates, we developed a clinical protocol to treat diffuse midline glioma in pediatric patients with IL13-PE co-infused with gadolinium-DTPA. We safely treated five patients with CED of IL13-PE. Gadolinium-DTPA successfully tracked drug distribution in real time using intraoperative MR imaging. We published our findings in 2018. This studys method of monitoring drug delivery and intratumoral treatment may be used for other CNS malignancies (1). Dr. Banasavadi is collaborating with investigators to develop virotherapy for glioblastoma (2). Virotherapy evokes oncolytic and immunologic effects that can potentially extend glioblastoma patient survival. Direct intratumoral injection of a viral vector distributes the vector near the needle tip, while convection-enhanced delivery techniques may spread the vector more broadly and improve virotherapys efficacy (1).

Neurodegenerative Disorders

We used a bench-to-bedside approach to treat the neurodegenerative disorder Parkinsons disease by convective delivery of Adeno-Associated Virus type 2 carrying the Human Glial cell line-Derived Neurotrophic Factor gene (AAV2-hGDNF). Parkinsons disease is progressive and presently incurable. GDNF is a neurotrophic factor that prevents the death of dopaminergic neurons in culture and animal models of Parkinsons disease (PD). Our study used escalating doses of AAV2-hGDNF, with six patients treated at the lowest dose, six at a higher dose, and 1 treated at the highest dose. Pre-operatively and at 6-12-month intervals post-operatively, the Unified Parkinsons Disease Rating Scale (UPDRS) Part 3 assessed motor function. Positron emission tomography (PET) scanning with 18FDOPA assessed F-DOPA uptake, a sign of presynaptic dopaminergic integrity. After treating 13 subjects, we stopped enrollment due to slow accrual. MRI tracked AAV2-GDNF infusion as it distributed to 22% of the putaminal volume. Patients with advanced Parkinsons disease tolerated the infusions without short- or long-term clinical or radiographic toxicity. UPDRS Part 3 assessment scores remained stable between before and 18 months after infusion. AAV2-hGDNF infusion improved F-DOPA uptake assessed by comparing 18FDOPA positron emission tomography (PET) scanning before, six months, and 18 months after AAV2-GDNF infusion. Increased 18FDOPA uptake in the infused areas was seen bilaterally in 10/13 patients at six months and 12/13 patients at 18 months after infusion. In 2019, we published these PET findings of increased putaminal 18FDOPA uptake, which suggested that AAV2-hGDNF had a neurotrophic effect on dopaminergic neurons. We collaborated with Dr. Bankiewicz in analyzing the long-term impact of AAV2-GDNF infusion on the infused brain area. We published an article describing the MRI findings as limited to the catheter track (3). One subject in the AAV-GDNF study died after cervical spondylosis surgery at another institution. The family consented to post-mortem brain examination and histopathology, which was performed and organized into a case report. In 2022, the final study patient completed the study, and we are writing a final study report.

Epilepsy

The FDA granted us an IND for intracerebral CED of muscimol to the brain to inactivate the epileptic focus temporarily. We recruited three seizure surgery candidates for the clinical study. The subjects entered the trial and underwent 1 to 2-day infusions into the seizure focus of muscimol. The infusions were well-tolerated. Recruitment ended after three subjects because short-term muscimol infusion did not permanently treat epilepsy. We published a manuscript in 2019 describing the studys findings. We stay enthusiastic about the translational development of drug-resistant epilepsy (DRE) therapeutic agents that selectively modulate or permanently inactivate the epileptic focus.

Muscle and Peripheral Nerve Disorders

The SNB supplied protocol-related sensory nerve biopsies in an NINDS clinical trial testing intrathecally delivered gene therapy for Giant Axonal Neuropathy. The SNB also performed muscle biopsies in a clinical trial for GNE myopathy.